Investigation in the role of L-type Ca2+ channel CaV1.2 in Achilles tendinopathy

PROJECT SUMMARY
The tensile-bearing Achilles tendon is highly prone to acute- or overuse-induced injuries that lead to chronic
tendon degeneration and heterotopic ossification (HO) called tendinopathy. Achilles tendinopathy is often
associated with pain and disability with high socio-economic costs. The current standard of care for treating
Achilles tendinopathy does not result in effective long-term functional recovery, although it provides short-term
pain relief. The pathogenetic mechanisms of Achilles tendinopathy are largely unknown. Identification of early
mediators in tendon in response to injury and elucidation of the cellular and molecular mechanisms underlying
the pathogenesis of this disease will facilitate the development of new therapeutic strategies. Using novel
transgenic mouse models with CaV1.2 wildtype or a gain-of-function mutant, we observed potent regulatory
effects of increased Ca2+ influx through CaV1.2 on the development of Achilles tendinopathy with
chondrocyte/osteoblast differentiation and ectopic bone formation. Using a reporter mouse line, our recent study
found that expression of the CaV1.2 channel in tendon fibroblasts is robust during development but very restricted
in adult Achilles tendons. In contrast, our preliminary data show substantial upregulation of Cav1.2 expression
in response to cytokine injection (TNF-α or IL-1β) or Achilles partial transection, an injury that induces Achilles
tendinopathy in wildtype mice. Substantial CaV1.2 channel expression is also observed in human diseased
Achilles tendon by immunohistochemistry analysis. These new findings provide a rational linkage between high
CaV1.2 expression and Achilles tendinopathy. Our population health studies of the TriNetX database further
provide clinical evidence suggesting that aberrant CaV1.2 expression/activity is a potential molecular mechanism
underlying Achilles tendinopathy. Therefore, we propose to test the overall hypothesis that increased Ca2+ influx
through CaV1.2 acts as an early pathological mediator of Achilles tendinopathy; decrease of Ca2+ influx through
CaV1.2 with L-type Ca2+ channel blockers (CCBs), conditional ablation of CaV1.2 or targeting a Ca2+-dependent
signaling cascade downstream of CaV1.2 in tendon cells will ameliorate Achilles tendinopathy. To test this
hypothesis, we propose three Specific Aims. In Aim 1, we will identify the tendon-specific role of Ca2+ signaling
through CaV1.2 in regulating endochondral differentiation in tendon during AT development. In Aim 2, we will
investigate CaV1.2 expression, the Ca2+ response and calcineurin activation in Achilles tendon in response to
inflammation and mechanical stimulation. In Aim 3, we will evaluate the ability of L-type CCBs as a
pharmacologic treatment to prevent and ameliorate Achilles tendinopathy in mice. We propose to fully
characterize CaV1.2 gain-of-function and loss-of-function mouse models, the CaV1.2 reporter mouse line, the
injury-induced mouse model, and surgically excised tendinopathy Achilles tissues from patients together with
Ca2+ imaging and pharmacological approaches to address these aims. The findings of this proposal could
provide a scientific rationale for repurposing the use of FDA-approved generic L-type CCBs to alleviate or treat
Achilles tendinopathy.

Public health relevance
PROJECT NARRATIVE Achilles tendinopathy causes pain and disability with high socio-economic costs. Current standards of care for treating Achilles tendinopathy are not effective for long-term functional recovery. The proposed work is expected to reveal whether increased Ca2+ influx through CaV1.2 Ca2+ channel acts as the early pathologic mediator of Achilles tendinopathy, providing a scientific rationale for repurposing the use of FDA-approved L-type CCBs to alleviate or treat Achilles tendinopathy.